Using latent cause modeling and neurofeedback to understand fear relapse and its relationship to anxiety

PROJECT SUMMARY/ABSTRACT
Exposure therapy is the most effective evidence-based treatment for a variety of anxiety disorders, but relapse
is common. Failures of exposure therapy can be explained in part by laboratory studies using aversive
conditioning and extinction, where the extinction phase can be viewed as a model of exposure therapy. These
studies show that the “safe” association learned during extinction is tenuous, and the original negative
association can sometimes return – a process known as spontaneous recovery. Recent work from our group
shows that during extinction, some participants update the original association from fear to safety while others
remember the fear association. The latter participants show spontaneous recovery (relapse) of fear at a later
test. The overall goal of this fellowship is to understand these individual differences in spontaneous recovery,
their relationship to transdiagnostic mental health symptoms of anxiety, and their neural underpinnings. To
accomplish this goal, I will leverage the computational framework of latent cause inference; according to this
framework, spontaneous recovery arises when an old latent cause associated with an aversive outcome is
inferred to be active in a harmless situation, a form of overgeneralization. I will fit a model to behavior of individual
participants to precisely quantify individual differences in the computational process underlying spontaneous
recovery and correlate these to symptoms. We will also identify the neurocognitive systems that are implicated
in this overgeneralization: we hypothesize that participants show spontaneous recovery because of deficient
memory-control processes – these participants are failing to suppress retrieval of the original memory, even in
the presence of evidence that the situation is now “safe”. We will relate this to clinical symptoms: based on prior
work, we hypothesize that spontaneous recovery will be associated with low memory-control ability and high
clinical symptoms of anxiety. Aim 1 will test for relationships between memory control, spontaneous recovery,
anxiety symptoms, and parameters of latent cause inference, taking a dimensional approach in a large-scale
online study. Aim 2 will causally test our hypotheses about brain networks that mediate spontaneous recovery
by intervening on these networks with real-time fMRI neurofeedback, with the goal of reducing spontaneous
recovery in individuals who are prone to it. Taken together, these studies will substantially advance our
understanding of why spontaneous recovery occurs and how it relates to clinical symptoms; this, in turn, can
inform our treatment of anxiety disorders by helping us identify who is most likely to relapse after exposure
therapy, and how we might intervene to prevent relapse.

Public health relevance
PROJECT NARRATIVE Exposure therapy is the most effective available strategy for the treatment of anxiety-related disorders; however, exposure frequently fails to prevent the return of symptoms, leading to relapse. The failures of exposure therapy can be understood through the computational framework of latent cause inference, a fundamental cognitive process that lies at the heart of how we generalize associative meaning across stimuli (i.e., fear and safety). Here, we use a computational model of latent cause inference and a novel fMRI neurofeedback intervention to gain insight into the mechanisms of extinction failure and how to prevent these failures from occurring.